Mechanisms of proteome curation during red blood cell differentiation

PROJECT SUMMARY
Red blood cells are responsible for circulating oxygen around the human body. To achieve this, differentiating
red blood cells must drastically restructure their proteome to enrich for hemoglobin, a tetramer of four globin
proteins that coordinate heme to bind oxygen. This occurs at a staggering rate: approximately two million blood
cells, each containing over 95% hemoglobin, must be produced every second to maintain health. A critical
factor for red blood cell production is UBE2O, a unique ubiquitylation enzyme within the ubiquitin-proteasome
system that degrades proteins. UBE2O has a quality control function of eliminating `orphan' proteins that fail to
assemble into the appropriate protein complex. These substrates include unassembled globin and ribosomal
proteins. UBE2O is also upregulated during late stages of red blood cell differentiation to mediate the
clearance of entire ribosome, the molecular machines that synthesize proteins. While ribosomes are needed
during initial stages of red blood cell differentiation to synthesize globin proteins, they must be eliminated for
terminal red blood cell differentiation to concentrate hemoglobin. How UBE2O accomplishes these tasks
essential for red blood cell function is not known. We recently established experimental and conceptual
foundations to dissect the mechanisms of protein ubiquitylation by UBE2O. In Aim 1, we will build on these
foundations to reconstitute the proteasomal degradation of UBE2O substrates with purified factors. This will
establish the minimal requirements for UBE2O-mediated protein quality control that occurs through a unique
multi-mono-ubiquitylation activity not typically associated with proteasomal degradation. In Aim 2, we will use
unbiased proteomics and structural studies to explore how different substrate adaptors tune the identities of
the proteins UBE2O targets for degradation. In Aim 3, we will identify new factors that work with UBE2O to
degrade entire ribosomes, which are large ~4 Megadalton complexes of approximately 80 proteins scaffolded
on 4 rRNA molecules, through proteasomes, which are restricted to degrading one protein at a time.
Successful completion of these aims will elucidate unique mechanisms that operate in the ubiquitin-
proteasome system to mediate protein quality control, ribosome homeostasis, and red blood cell differentiation.
Such molecular-level insights will generate precise hypotheses to test in complex physiological models and
facilitate our understanding of how these processes contribute to blood disorders and the identification of new
therapeutic strategies.

Public health relevance
PROJECT NARRATIVE Humans make approximately two million red blood cells every second. This proposal investigates the mechanisms of UBE2O, an enzyme critical for remodeling the contents of developing red blood cells so that they can efficiently circulate oxygen. Molecular-level knowledge of how UBE2O modifies proteomes may reveal insights into the etiology and treatment of blood disorders and cancers linked to its activity.